AqNWB - Enabling data acquisition in the Neurodata Without Borders data standard

PROJECT SUMMARY
The goal of this project is to enhance the sustainability and impact of AqNWB, an open C/C++ API for enabling
direct data acquisition in the Neurodata Without Borders (NWB) data standard. With the increasing adoption of
NWB as the leading format for sharing neurophysiology data, there is a pressing need to support its use
throughout the entire data lifecycle—from acquisition and processing to analysis, publication, and reuse.
Currently, researchers typically acquire data in system-specific formats and convert their data to NWB later for
analysis and sharing, a process which is inefficient and error-prone. AqNWB aims to address this challenge by
allowing direct data acquisition in NWB, thus streamlining laboratory practices and promoting FAIR data
principles. This proposal will enable us to ensure AqNWB’s readiness for production use (Aim1) and to
promote its adoption through integration with leading neurophysiology data acquisition software (Aim 2).
Specifically, Aim 1 focuses on enhancing production readiness of AqNWB by improving reliability through
enhanced testing workflows, simplifying installation via standardized deployment processes, and increasing
usability with better documentation and tutorials. Additionally, Aim 1 will enhance support for multi-modal
neurophysiology data acquisition by enhancing AqNWB to support optical physiology and behavioral NWB
data types. Aim 2 aims to facilitate the integration of AqNWB with leading neurophysiology data acquisition
systems to promote broader adoption. This work will involve the development of advanced I/O features for
large-scale data acquisition, including customization of chunking and compression settings and integration of
Zarr as a new storage backend to enhance parallel write and cloud support. AqNWB will be integrated with
OpenEphys in the first year, and further integration targets (e.g., SpikeGadgets, ScanImage, and BPOD) will
be prioritized in the second year. By leveraging best practices in open-source software development and
collaborations with leading data acquisition systems, this project will enhance the sustainability and impact of
AqNWB as a valuable tool for neuroscience research and promote the widespread adoption of NWB. Beyond
the innovations in the AqNWB software, this project will remove the need for post-acquisition data conversion,
thus streamlining laboratory data management practices and promoting FAIR data practices by enabling use of
NWB throughout the data lifecycle.

Public health relevance
PROJECT NARRATIVE The goal of this project is to enhance the sustainability and impact of AqNWB, an open C/C++ API for enabling direct data acquisition in the Neurodata Without Borders (NWB) data standard. To meet the growing demand and need of data acquisition systems to support direct acquisition of data in the NWB format, we will enhance the production readiness of AqNWB to facilitate use in research practice (Aim 1) and promote its adoption through integration with leading neurophysiology data acquisition software (Aim 2). By leveraging best practices in open-source software development, this project will enhance the sustainability and impact of AqNWB as a valuable tool for neuroscience research and enable seamless use of NWB throughout the entire data lifecycle by eliminating the need for post-acquisition data conversion.